Strain and Bone Fracture Healing: Image-Based Mechanics Models to Redefine the Rules

PROJECT SUMMARY
The long-term goal of this research is to understand the mechanical factors that influence bone fracture healing
in large animals and humans. In the early stages of bone healing, the fragments of a broken bone can move
relative to one another. These small movements stretch the soft tissues that are involved in early fracture repair,
producing a mechanical effect known as strain. Since the 1970s, strain has been strongly linked with the biology
of fracture repair, but the conceptual framework for explaining strain in the context of bone healing has not
evolved in four decades. Today, orthopaedic surgeons are keenly aware that strain regulates fracture healing,
but they cannot measure it in their patients. Authoritative clinical textbooks are riddled with nonspecific, alarming,
and impractical advice about the risks of fixing a fracture with a bad strain environment. In the absence of clear
guidance, surgeons learn to rely on biomechanical rules of thumb for how to select the right implant for certain
types of fractures. Decades of mixed messaging and indirect discussion about strain and bone healing have
created significant barriers to innovation in clinical training and implant design. There is now a major unmet need
to develop innovative new research tools that can provide insights on how mechanical strain regulates bone
healing. To address this need, we will bring together a suite of sophisticated physics-based models and image
analysis techniques to do what has been impossible until now: directly assess strain at the tissue level and show
its association with the processes of fracture healing. This research has two technical aims. For the first aim, we
will use micro-computed tomography (µCT) scans to create 3D virtual reconstructions of the shinbones of sheep
with fractures that healed after surgery. We will simulate gait-induced loads on the bones and use the models to
measure strain in and around the fracture line. Strain measured from the models will be spatially correlated with
the new bone formation and a threshold for allowable strain will be determined. In the second aim, the focus will
be on adaptive changes that occur in old bone near a healing fracture. The image-based models will again be
used to measure strain, but now spatial cross-correlation of high-resolution data from the images will be used to
assess whether strain on the outer surface of the old bone is associated with an internal loss of bone mineral
density compared to before the injury. The results from this project will pave the way for a new paradigm of
thinking about strain and bone healing. Although we will be studying sheep, the groundbreaking methodologies
developed for this project have high translational potential for use in clinical research. The same types of
modeling and image data-mining techniques could be used to study fracture healing in human patients. This will
ultimately help improve clinical decision-making for treatment of complex fractures, where there is still
considerable debate among surgeons about how much strain is biomechanically optimal for fracture healing.

Public health relevance
PROJECT NARRATIVE The ability of a bone fracture to heal depends on its mechanical stability after surgery, but surgeons cannot directly measure this, so the care of complex fractures remains fraught with guesswork informed by rules of thumb. This research will develop techniques for using physics-based simulations and 3D imaging data to measure the mechanical conditions that drive early bone healing. These methods have high potential to improve clinical decision-making for the care of certain types of fractures where there is considerable debate about how to get the best healing response for patients.